Summer Research Experience in Cancer(SuRE-C)

ABSTRACT
The overarching goal of our ten-week Summer Research Experience in Cancer (SuRE-C) Program is to
exploit the rich and diverse cancer research community at the University of Virginia (UVA) to provide an
immersive and inspiring experience in cancer research for undergraduate and medical student trainees,
awakening their potential as cancer researchers. To accomplish this, the aims of this NCI-supported
program are to: (1) expose trainees to the state-of-the-art cancer research through an immersive, hands-
on experience within in our research groups; (2) introduce trainees to the synergy that results from a
robust partnership between basic cancer researchers and clinical care providers; (3) instruct
trainees how to communicate about cancer discovery with audiences from different backgrounds and
levels of expertise (4) inform trainees about career options in cancer research and the training
requirements and opportunities associated with each of those careers; and (5) Provide trainees with
important professional development skills and a networking foundation that can serve as a
springboard to launch their research careers. This application seeks support to continue this successful
program which funds the training of fifteen (15) undergraduate and/or post-baccalaureate students and
five (5) rising second-year medical students enrolled in SuRE-C each summer. Through hands-on cancer
research, innovative educational initiatives, exposure to a wide range of cancer-related research and
clinical care experiences, and a strong mentoring network, SuRE-C trainees will be uniquely prepared to
pursue advanced training and become valued members of a diverse cancer research workforce.

Public health relevance
NARRATIVE The landscape of biomedical research in the United States is changing, as are the composition and activities of the biomedical research workforce. With this evolution comes an increasing need to encourage talented young people to explore this changing landscape and pursue careers that will contribute to a better understanding of the factors that promote the diseases under investigation, the development of methodologies to predict and/or prevent disease progression, and the discovery of therapies that will help cure patients. The Summer Research Experience in Cancer (SuRE-C) Program at the University of Virginia will continue to address this need by providing undergraduate and medical student trainees with an immersive research experience within a rich cancer research community that boasts strong and diverse basic science, an NCI-designated Comprehensive Cancer Center, and opportunities for exposure to the practice and challenges of providing clinical care to cancer patients.